Detrimental Effects of B-Cell-Th17 Axis in Antiviral Immunity in Smokers.

Smokers are at increased risk for viral-induced respiratory failure and hospitalization. We have shown that
cigarette smoking (CS) induces systemic inflammation characterized by increased interleukin 17A (IL-17A)
expression in CD4 T helper (Th)17 cells in mice and humans. CS promotes Th17 cell differentiation in the lungs
while reducing several key transcription factors critical in protecting against viral infection. Mice exposed to
chronic CS and infected with influenza A virus (IAV) have increased IL-17A in the lungs, reduced flu-specific B
cells, and increased mortality compared to controls. Consistently, in a prospective study, we have found that
active smokers vaccinated against seasonal IAV have reduced flu-specific neutralizing antibody titers two
months post-vaccination. Together, these findings indicate a strong link between smoking and reduced flu-
specific memory B cell (Bmem) development. CD4 T follicular helper (Tfh) cells and dendritic cells (DCs) play a
key role in mediating the selection and survival of B cells that differentiate into plasma cells, however, how CS
changes their development or function remains unknown. Therefore, significant knowledge gaps include whether
i) Tfh cells and DC numbers and/or function are perturbed in smokers with increased levels of IL-17A, and ii) B
cell-Th17-axis impairs flu-specific antibody production and virus-specific Bmem development. Our central
hypothesis states that CS increases IL-17A in the lungs which impairs the differentiation and/or function of Tfh
subsets and DCs, decreasing protective immunity against IAV.
We have assembled an outstanding team of physicians, immunologists, and bioinformatics to test our hypothesis
with Specific Aims: Aim 1) Determine the mechanism of CS-induced loss of long-term protective flu-specific B
cell immunity. Rationale: compared to controls, mice exposed to CS and IAV have increased Th17 cells in the
lungs, reduced flu-specific antibodies, and blunted HA-specific B cell responses. This aim will test the hypothesis
that active CS induces IL-17A in the lung that alters systemic and transcriptional factors required to produce
protective Bmems. Aim 2) Determine flu-specific memory B cell function and transcriptomic changes in the lungs
of smokers. Rationale: compared to controls, active smokers have increased Th17 cells and reduced flu-specific
Bmems in the lungs. This Aim will test the hypothesis that ineffective expansion of flu-specific Tfh cell pool in the
lung correlates with poor Bmem survival and lack of high-affinity antibodies against IAV in humans. Aim 3)
Determine the mechanism involved in systemic immune responses to flu antigens in smokers. Rationale:
compared to controls, active smokers show reduced neutralizing antibody titers following flu vaccination. This
Aim will test the hypothesis that CS induces systemic changes to the immune cell transcriptome required to
develop protective Bmems in response to seasonal flu vaccination. Impact: Unraveling the mechanisms for
failure to develop protective antibodies against flu in smokers provides critical evidence for designing human
clinical trials and testing new treatments for this at-risk population.

Public health relevance
We have previously found that smokers have reduced protective antibodies against influenza and mice exposed to cigarette smoke can't produce a strong defense against influenza and die from the infection. We plan to study how cigarette smoking prevents the appropriate protection against influenza infection. We will use a mouse model of cigarette smoking that shares many features with humans, and human lung tissue from smokers and nonsmokers to study the defect in developing an appropriate protective response to influenza.